Not-For-Profit Hospital Community Benefit: Multi-Sectoral Collaboration in Local Health Planning to Improve Population Health, Equity, and Hospital Investment in the Social Determinants of Health

Project Summary
Federal and State-level community benefit (CB) requirements for not-for-profit hospitals (NFP) have been
around for decades. Historically, most of hospital CB spending is on unreimbursed patient care despite the
expectation that NFPs align their CB spending with broader community needs that often require investments in
non-clinical areas. Federal regulations aside, a few states have experimented with CB regulations to increase
NFPs’ investment in community health and to focus their CB activities on specific community health priorities.
New York, Ohio, and Oregon are among the first states to require NFPs to collaborate with local health
departments (LHD) and other community partners in assessing and prioritizing community needs. Additionally,
Oregon set a minimum CB spending floor using a formula that calculates the threshold based on the financial
health of hospitals. While these NFP regulations and the decision to implement them predated the pandemic,
the regulations have the potential to leverage CB investments in alleviating long-standing inequities and
addressing social determinants of health (SDOH) worsened by the pandemic. The purpose of the study is to
estimate the effect of NY, OH, and OR regulations on NFP spending in non-clinical categories of CB, SUD-
focused health outcomes, and health equity. To accomplish this, the study will use different causal inference
methods and longitudinal CB spending data, data on emergency department utilization and transitions of care,
and information from NFPs’ implementation strategies. The in-depth case studies will elucidate the mechanisms
through which the requirement for collaboration works, refine the theoretical framework, inform the
improvement of existing policies and implementation in other jurisdictions, and to generate new hypotheses.
This K01 support will help me acquire the necessary experience to develop rigorous theoretical frameworks
by integrating organizational and management science with economic theory. Additionally, this K01 will support
my development in innovative conceptualization of health equity and community-engaged qualitative research.
This project will lead to an application for R01 funding to examine the impact of multi-sectoral collaboration on
a broader set of population health outcomes and health equity. The R01 proposal will expand the
multi-sectoral collaboration to include additional community partners. This K01 is well-aligned
with AHRQ’s overarching goals. First, the focus on “the role of partnerships between the community and health
systems in impacting SDOH and improving health outcomes” will inform AHRQ’s goal of “achieving a high value
healthcare system”. Second, the focus on the effectiveness of NFP-LHD collaboration to address the SUD
epidemic is linked to AHRQ’s goal to understand “the SUD crisis and provide solutions for addressing it”. Finally,
the study examines the impact of NFP-LHD collaboration on outcomes by race, ethnicity, and geography which
aligns with the agency’s goal to advance health equity while focusing on specific priority populations.

Public health relevance
Project Narrative Collaboration between health systems and community partners have the potential to effectively address the social determinants of health and improve population health equity. The community benefit program for not- for-profit hospitals can be leveraged to require multi-sectoral collaboration and provides a natural experiment to understand whether multi-sectoral collaboration if effective. This proposal, through a supervised mentorship and training program, aims to examine the impact of collaboration between hospitals, health departments, and other community partners on population health equity and hospital investment in SDOH.